Development and validation of novel models for cerebral small vessel disease and vascular cognitive impairment

PROJECT SUMMARY
Vascular cognitive impairment and dementia (VCID) is any level of cognitive alteration that is attributable to
cerebrovascular pathologies. VCID is second only to Alzheimer's disease as a cause of dementia and
accounts for ~15-30% of all dementia cases. Cerebral small vessel diseases (cSVDs) are group of pathologies
afflicting the microcirculation of the brain that collectively account for up to 20% of all strokes and is the most
common pathology underlying VCID. The impact of cSVD and VCID is expected to increase rapidly as the
population of the US and other countries ages. Importantly, the pathogeneses of cSVDs are incompletely
understood which represents a major barrier in developing strategies for prevention and treatment. Research
described in this proposal will develop and validate five novel mouse models of cSVD based on genes and
mutations that are demonstrated to contribute to human disease. We have assembled an interdisciplinary team
of experts that will integrate unique genetic resources, vascular pressure myography, patch-clamp
electrophysiology, calcium imaging, specialized magnetic resonance imaging modalities and learning and
memory behavior assays to develop and characterize multiple novel genetic models of cSVD using genes that
contribute to disease in humans. Our long-term objective is to develop and employ genetic models that
faithfully recapitulate important hallmarks of human cSVD and VCID.

Public health relevance
RELEVANCE Cerebral small vessel disease (cSVD) is a major cause of vascular cognitive impairment and dementia (VCID) – an important sub-group of Alzheimer's disease-related dementias (ADRD). The molecular mechanisms underlying cSVD are largely unknown and improved experimental models of cSVD would greatly aid our understanding of ADRD pathophysiology. We propose to address this urgent unmet need by developing and validating novel genetic models that address traditional barriers.